Active Help, Immune Function and Health Outcomes in Alzheimer's Caregivers

This proposal uses ecological momentary assessment (EMA) methods to examine
how the provision of active help to individuals with Alzheimer’s Disease and related
dementias (ADRD) influences the immune system and health of ADRD caregivers.
We hypothesize that caregivers who feel emotionally close to the care recipient will
show improvements in immune system biomarkers, self-reported health outcomes,
and health-related quality of life as their active help increases. Two hundred and
fifty caregivers will be recruited from the Center of Excellence for Alzheimer’s
Disease of Long Island to participate in a three-wave longitudinal study in which we
will collect data at baseline, 6 months, and 12 months. We will use EMA methods to
collect data on active help and the caregiving context at baseline and 6 months, and
and we will assess immune system activity and self-reported health outcomes at
baseline, 6 months, and 12 months. Our analyses will test whether active help is
beneficially associated with makers of inflammation (e.g., Il-6/TnF alpha-receptor)
and repair (e.g., SOD, progesterone) among caregivers who feel emotionally close to
the recipient.

Public health relevance
PROJECT NARRATIVE The proposed work seeks to examine the stress, immune system, and health consequences of active help in caregivers of person’s with Alzheimer’s disease and Related Dementias. This work promises to illuminate avenues for improving caregiver health and well-being. If successful, this work will lead to the design of psychosocial interventions for caregivers.